Administrative Core

Summary. The Administrative Core will oversee all planning activities involved in establishing the
infrastructure and research partnerships needed to support the CCHRC’s future research and thus ensure that
the Community Catalyst (Climate health equity research center) CCHRC’s goals are achieved. Led by a
transdisciplinary team with substantial experience in large clinical research networks with similar infrastructure
and administrative needs, the Administrative Core will conduct the following tasks. (1) Oversee and support all
planning process operations by serving as the coordination hub for all CCHRC efforts, including: strategic
planning for the CCHRC’s sustainment post-planning period; managing budget and resources; meeting
regulatory, reporting, and human subjects protection requirements; tracking and coordinating all Cores’
activities; collaborating with the national CCHRC network and funding agency; and coordinating the External
Advisory Board. (2) Direct all CCHRC capacity building and sustainment planning activities, including: creating
the CCHRC’s highly innovative data infrastructure by linking EHR data from OCHIN’s national network of
primary care community health centers (CHCs) and the Harvard Confluence Project’s granular data on climate-
induced heat and air quality events, yielding a nationally unique data resource that will be available to
collaborators; supporting the creation of a transdisciplinary Learning Community of scientific and community
partners that generate a research agenda aimed at mitigating climate-induced health impacts in CHC
populations; developing at least two large research funding proposals designed to meet identified research
needs; supporting two early-stage investigators’ development; and creating a health informatics tool that
integrates real-time data on extreme climate events (heat spikes, poor air quality) into the EHR shared by
OCHIN’s CHCs, to support future interventions using these data. (3) Widely disseminate and translate findings
both within and beyond the CCHRC’s Learning Community to inform the action-oriented spread of new
knowledge to diverse stakeholders and target audiences. (4) Rigorously evaluate the progress of the CCHRC
planning process in meeting its goals and objectives, regularly update CCHRC leaders and funders on
evaluation findings, and adapt processes as necessary. By completing these tasks, the Administrative Core will
optimize the CCHRC’s ability to generate a much-needed long-term body of research on the mitigation of
climate-induced health impacts in the marginalized U.S. populations served by primary care CHCs.